State-dependent control of nociception in opioid circuits

ABSTRACT │ The perception of pain does not scale linearly with peripheral nociception. This highly modifiable
feature of pain is tuned by a range of contexts: internal emotional or interoceptive states, as well as expectations
and beliefs involving future outcomes that might make pain worse or better. One form of pain modulation is
placebo analgesia—an endogenous antinociception process in which perceived pain is reduced by a treatment
that has no pharmacological effect but relies on expectations of pain-relief. While fMRI has provided a roadmap
of distributed brain circuits involved in placebo analgesia, in particular associative cortical areas, the amygdala,
and the ventrolateral periaqueductal gray (vlPAG), the dynamic role of distinct cell-types and neuropeptides for
placebo mechanisms involved in endogenous antinociception are unknown. The vlPAG is enriched in mu opioid
receptors (MORs) and opioid peptides, such as enkephalin (ENK). While the vlPAG is a principal site of morphine
antinociception, fundamental gaps in knowledge remain regarding nociception-related endogenous opioid
signaling mechanisms: are there coordinated and opposing activities between different opioid cell-types during
pain-relief; under what noxious conditions and learned expectation contexts is ENK released and what are the
temporal dynamics of ENK release? Our preliminary results find that vlPAG MOR+ neurons projecting to
forebrain areas broadly respond to noxious stimuli and may be modulated by endogenous ENK release arising
from local and reciprocal afferent structures, such as the central amygdala. The proposed experiments, across
3 Specific Aims, will build greatly from these findings by combining a new model of rodent placebo-like analgesia,
optogenetic control of functional-genetic cell-types, single-neuron resolution dual-color calcium + biosensor
imaging, and development of a new red-fluorescent ENK biosensor. Our overall approach will permit the
investigation of vlPAG local and long-range circuits with single-cell resolution and millisecond timescales to link
the rapid dynamics of this pain modulation system with behavioral metrics of analgesia under contexts of
instrumental pain-relief. Uncovering placebo analgesia mechanisms provides important opportunities to
understand this clinically-relevant phenomena at the level of functional ensembles and cell-types, and to launch
efforts that aim to harness this endogenous pain modulation system for effective chronic pain management.

Public health relevance
NARRATIVE │ Chronic pain is a significant healthcare challenge, and our research aims to understand natural pain-relief mechanisms during placebo responses in the vlPAG (ventrolateral periaqueductal gray) opioid circuits connected to the midline thalamus. By studying how expectations influence opioid signaling, we hope to harness these insights for better pain management. Using advanced dual-color imaging and cell-specific optogenetics, we will map neural activity and neuropeptide release during endogenous analgesia. This work could redefine therapies that leverage the body's natural pain-relief pathways.